Regulation of the lymphoid cell fate by Hoxa9

PROJECT SUMMARY
Steady-state hematopoiesis in bone marrow is critical for maintenance of blood cell genesis and immune
competence throughout life. Concomitant with aging, the bone marrow hematopoietic stem cell (HSC)
compartment undergoes cell intrinsic and extrinsic changes that biases hematopoietic output toward the
myeloid lineage. The bias in HSC-subset predominance and change in hematopoietic output contributes to
immune dysfunction in the elderly including an increased propensity to infection and lessened vaccine
responses. Thus, studies focused on understanding essential regulators that support a non-biased, balanced
HSC pool that supports lymphoid differentiation capability has the potential to provide novel therapeutic
avenues to rejuvenate HSC developmental trajectories to restore immune function in the aged. The homeobox
transcription factor Hoxa9 is expressed in primitive HSCs and is inactivated upon lineage commitment. Mice
with germline deletion of hoxa9 are viable but display multilineage deficiencies that are transplantable,
confirming a cell intrinsic defect. Competitive transplantation experiments revealed impaired long-term
repopulating ability and in vitro studies showed poor proliferative responses to early-acting cytokines. In bone
marrow, hoxa9-/- mice exhibit reduced cellularity, impaired lymphoid priming, reductions in lympho-myeloid
progenitors, common lymphoid progenitors, and B cell precursors. Hoxa9-/- mice also have smaller thymi, and
reductions in early thymic progenitors. Interestingly, flow cytometric analysis of the long-term repopulating stem
cell compartment (LT-HSC) in young adult hoxa9-/- mice revealed increased frequencies of LT-HSCs
expressing high levels of the CD150, which is functionally associated with myeloid skewing. This is contrasted
by significant decreases in frequencies of CD150lo LT-HSC in hoxa9-/- marrow, which have balanced lympho-
myeloid potential. Increased numbers of myeloid-biased HSCs along with diminished lymphopoiesis is
reminiscent of aging. A Hoxa9 target gene implicated in age-associated alterations in lymphopoiesis and B cell
genesis in the marrow is p16ink4a. The cyclin dependent kinase inhibitor p16ink4a is virtually undetectable in
HSC and B cell precursors from young mice but increases in both subsets with age. Realtime PCR of Lin-
Sca1+ hematopoietic progenitors from young hoxa9-/- mice revealed increased mRNA transcripts for
p16ink4a. To determine if over expression of p16ink4a was the molecular basis of the lymphoid/B cell
deficiency in hoxa9-/- mice, we generated hoxa9-/-p16ink4a-/- mice. Importantly, deletion of p16ink4a restored
bone marrow and thymus cellularity and rescued the deficiencies in lymphoid, B and T cell precursors in
hoxa9-/- mice. These novel experimental findings support the hypothesis that Hoxa9 suppression of p16ink4a
is critical for lymphopoiesis. At present, there is a paucity of information regarding the role of Hoxa9 in
regulation of lympho-hematopoiesis. The studies detailed in this proposal are aimed at filling this gap in the
knowledge.

Public health relevance
PROJECT NARRATIVE Steady-state hematopoiesis in bone marrow is critical for maintenance of blood cell genesis and immune competence throughout life. Concomitant with aging, the bone marrow hematopoietic stem cell (HSC) compartment produces fewer lymphoid lineage progeny and the molecular basis remains unknown. The goal of this project is to determine the role of the HOX protein Hoxa9 in regulation of lymphopoietic potential from HSC.